Recombinant Virus Vaccines

There are many diseases for which there are no vaccines and others for which the vaccines are not optimal or have significant side effects. The objectives of this project are to develop new vectors, characterize viral antigens, determine targets of humoral and cell mediated immunity, and use this information to develop candidate vaccines. Live recombinant viral vaccines, DNA vaccines and recombinant protein vaccines are being developed.

The attenuated vaccine vector known as modified vaccinia virus Ankara (MVA) was derived by extensively passaging the parental strain of vaccinia virus Ankara in chick embryo fibroblasts and is unable to replicate in most mammalian cells. The MVA host range restriction is exceptional in that synthesis of the abundant viral proteins appears unaffected, but morphogenesis of virus particles is abortive. Use of MVA for SARS-CoV-2 vaccines is described in another project.

In previous studies, we demonstrated that three vaccinia virus proteins induce neutralizing antibodies that protect against vaccinia virus and monkeypox virus infections in mice and non-human primates. Further studies to improve vaccine response are in progress.